In vivo investigations of astrocyte-oligodendrocyte interactions

PROJECT SUMMARY
Proper nervous system function depends not only on functional interactions between neurons and glia, but also
between different types of glia. This proposal is focused on defining fundamental properties of interactions
between two major classes of glia in the vertebrate nervous system: astrocytes and oligodendrocytes.
Astrocytes are the most abundant glial cell type in the human brain and are important for central nervous
system (CNS) development and function. Astrocytes are elaborate cells that extend processes that contact
synapses, neurons, blood vessels, and other glial cells in the CNS. Oligodendrocytes are the myelinating glia
of the CNS; they wrap axons with myelin to facilitate rapid action potential propagation and provide vital trophic
support to neurons.
Our long-term goals are to understand how astrocytes and oligodendrocytes functionally interact. We know
that astrocytes and oligodendrocytes are connected by gap junctions and that astrocyte factors can promote
myelination and remyelination. Yet the cellular and molecular bases of these interactions are incompletely
understood. Our preliminary data using in vivo imaging in zebrafish demonstrate a wealth of different forms of
physical interactions between astrocytes and oligodendrocytes in the developing spinal cord. This proposal will
use a combination of molecular, genetic, cellular, and proteomic tools to: fully define astrocyte-oligodendrocyte
myelin interactions at the cellular and molecular levels; to define novel proteins at the astrocyte-myelin
interface; to understand how oligodendrocyte development and myelination are impacted when astrocyte
development is altered. Our work will provide exciting new insights into how astrocyte and oligodendrocyte
interactions contribute to proper nervous system function in vivo and provide a foundation for understanding
the properties of these cells in human disease states.

Public health relevance
PROJECT NARRATIVE Astrocytes and oligodendrocytes are critical support cells that regulate function and maintenance in the vertebrate nervous system, and disturbances to these cells can result in neurological deficits. We propose to study fundamental properties of astrocyte-oligodendrocyte interactions in the nervous system. This work has implications for human disease including multiple sclerosis and leukodystrophy.